Quantitative and Spatially-Resolved Analysis of the Tumor Immune Contexture for Optimal Diagnosis and Treatment of Lung Cancer

Project Summary
Not required for this submission

Public health relevance
Project Narrative Not required for this submission